Physical Chemistry of Nucleic Acids

Project Summary
In eukaryotic cells, the packaging of genomic DNA into nucleosomes represents the basic barrier to
transcription by RNA polymerase II (Pol II). The dynamic modulation of the magnitude of this barrier and the
degree of chromatin compaction constitute fundamental mechanisms of regulation of gene expression. Having
previously characterized the magnitude and mechanical properties of the nucleosomal barrier and their effect
on Pol II transcription, we aim to investigate the modulation of this barrier and its regulation of genome
accessibility to Pol II by environmental and cellular factors. We will do this by combining single-molecule
optical tweezers/fleezers (SM-OT) methods with high-resolution single particle cryo-electron microscopy
(cryo-EM), cryo-electron tomography (cryo-ET), and quantitative in vivo fluorescence imaging.
We have determined that nucleosomes display a trimodal distribution of unwrapping forces
corresponding to alternative nucleosome states that we hypothesize represent different barriers to
transcription by Pol II. We will investigate this intrinsic plasticity of nucleosomes and its modulation by factors
that promote their interconversion, including histone variants, post-translational modifications, and specific
transcriptional regulators (pioneer factors, elongation factors, and histone chaperones).
Next, we will use our SM-OT assay to investigate how specific transcriptional regulators (e.g., FACT,
Spt4/5, Chd1) affect the dynamics of Pol II as it transcribes through the nucleosomal barrier. We will also
explore how histone PTMs, that have either activating or repressive roles on transcription, modify the
molecular trajectories and dynamics of individual Pol II molecules. Moreover, we will study how Pol II crosses
hexasomes and tetrasomes, both generated during moderate and intense transcription and that have been
proposed to play important roles in vivo. We will structurally characterize the nucleosome remodeling during
passage of Pol II by cryo-ET both in the presence or absence of transcription regulators.
In eukaryotic cells, gene expression requires the passage of Pol II through arrays of nucleosomes
organized as chromatin. These arrays can adopt higher-order and more compacted structures that impose a
greater barrier to transcription by Pol II. Therefore, to understand how nucleosome arrays regulate genome
accessibility, we will study their mechanical stability using SM-OT unwrapping assays and characterize the
energetics of internucleosome interactions in these structures. We will also investigate the impact of
nucleosomal arrays on the transcription dynamics of individual Pol II using SM-OT in the absence and
presence of transcription regulators, and under different conditions that modulate chromatin compaction. We
will compare the dynamics of Pol II obtained in these in vitro experiments, with its dynamics in vivo. To this
end, we will introduce the strong nucleosome position sequence 601 into Drosophila embryos and monitor the
effect of single vs multiple nucleosomes on the rate of transcription by Pol II via quantitative live-cell imaging.

Public health relevance
PROJECT NARRATIVE Chromatin and its fundamental unit, the nucleosome, constitute a mechanical barrier that controls DNA accessibility and is, therefore, a major mechanism of control of gene expression. Here, we combine biophysical approaches including optical tweezers, single-molecule fluorescence, cryo-electron microscopy/tomography, and in vivo quantitative confocal imaging to investigate how epigenetic modifications, pioneer factors, chromatin remodelers, chromatin- associated proteins, and histone chaperones modulate the magnitude of the mechanical barrier of a single nucleosome and nucleosome arrays, and how they affect transcription by Pol II. The precise measurement of these mechanistic details will provide the physical framework to understand how gene expression is regulated by chromatin.